Strengthening Surgical Scientists Capacity for NCD-Lifespan Research (SSSCAR) Program

Strengthening Surgical Scientists Capacity for NCD-Lifespan Research (SSSCAR) Program
Project summary
Non-communicable diseases (NCD) are now the most common causes of morbidity and mortality globally
and their prevalence is rising, particularly in low- and middle-income countries (LMIC). The rising incidence and
mortality rates of NCDs in Africa require novel, context-specific, resource-level appropriate research into the
epidemiology, prevention and management strategies that leads to improved public health and clinical outcomes.
Up to 60% of the NCDs occurring across the lifespan in LMICs are surgically amenable NCDs. Despite
the high burden of surgically amenable NCDs, there has been little investment in surgical global health training
and research particularly in LMICs where surgery has been overwhelmingly focused on patient care.
In the SSSCAR Program, the University of Maryland School of Medicine (UMSOM), the Center for
Bioethics and Research, Ibadan, Nigeria (CBR), and the National Open University of Nigeria (NOUN) collaborate
to build the capacity of the West African College of Surgeons (WACS) trainees by implementing multidisciplinary
graduate training programs that would empower WACS trainees to address surgically amenable NCDs across
the lifespan among women, support trainees’ career development and generate public health and clinical
benefits for surgical patients.

Public health relevance
Strengthening Surgical Scientists Capacity for NCD-Lifespan Research (SSSCAR) Program Project narrative Non-communicable diseases (NCD) are now the most common causes of morbidity and mortality globally and their prevalence is rising, particularly in low- and middle-income countries (LMIC) where a substantial proportion are amenable to surgical intervention. Yet, there has been little investment in surgical global health training and research causing it to be described as the “neglected stepchild of global health”. In this program, the University of Maryland School of Medicine (UMSOM), the Center for Bioethics and Research, Ibadan, Nigeria (CBR), and the National Open University of Nigeria (NOUN) collaborate to build the capacity of the West African College of Surgeons (WACS) trainees by implementing a multidisciplinary graduate training program to build capacity for research on NCDs across the lifespan, particularly in women.